Research Core Methods

Project Summary Research Methods Core C
The Methods Core will provide services and training in statistical analysis techniques, research design, mental
health (MH) measurement, and data management. With the University of Miami Developmental AIDS
Research Center (UM D-ARC)’s emphasis on Reducing the Impact of Mental Health and Minority Health
Disparities across the HIV Prevention and Care Continua we focus on multi-level methods. MH co-
morbidities are inherently individual-level processes. In contrast, MH and minority health disparities are driven
by higher-level structural socio-cultural processes that exist at the various levels (e.g. neighborhoods, cities,
regions) within which the individual is nested. Therefore, interventions and approaches of center investigators
are likely to address both individuals as well as these socio-cultural processes and, thus, be multi-level.
The Methods Core has three aims. Aim 1: To promote use of appropriate state-of-the-science
research design and statistical methods in multi-level research that will inform local implementation of
evidence-based practice consistent with the UM D-ARC theme and goals. Activities to address this aim
will include providing consultation to HIV/AIDS MH researchers developing NIH grant proposals (as well as
post-award support) and supporting early stage investigator with UM-ARC pilot studies in the areas of research
design, use of biomarkers of HIV and its comorbidities, and statistical analysis strategies. Aim 2: To create,
maintain, and facilitate use of a centralized data repository and an instrument library as resources for
high-impact research on MH and minority health disparities in HIV/AIDS. This will include a voluntary
unified data architecture that includes common data elements to facilitate collaboration and cooperative
projects to utilize D-ARC data in innovative new ways and a REDCap instrument library including Spanish and
Haitian Creole-language measures. We will provide access to existing electronic data collection forms and
instruction on how to create new electronic data collection forms for new measures. Aim 3: To provide
triaged access to other UM D-ARC Core resources as well as state-of-the science methodology
workshops and other capacity-building activities that complement and expand existing UM resources
to focus on MH disparities in HIV/AIDS. Activities to support this aim include creation of a comprehensive
Research Navigation Platform to coordinate access to D-ARC methodology consultations and all Center
resources; and conducting new methods-focused workshops with content on multilevel modeling, GIS mapping
of MH outcomes, methods for identifying subgroups and estimating treatment effect heterogeneity, approaches
to implementation research, and model selection approaches. The Core will also facilitate consultations and
presentations from other D-ARC cores and affiliated research groups, such as the CFAR, CTSI, NIDA’s
National Drug Abuse Treatment Clinical Trials Network, and NIDA’s P30 CHERISH Center, which focuses on
cost-effectiveness analysis.

Public health relevance
Project Narrative for Other Components Please see Overall Component for Project Narrative. PAR-15-196 Guidelines Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components. SF424 Guidelines Overall Component: The "Project Narrative" attachment is required. Other Components: Refer to the specific FOA to determine whether the "Project Narrative" attachment is required for any Other